The Wilmer Institute Mentored Clinician Scientist Scholar Program

Project Summary/Abstract
In its renewal application, the Wilmer K12 Program seeks to continue its successful recruitment and
development of new investigators in highly relevant areas of clinical and laboratory vision research. Our past
track record indicates success in mentored training of young scientists who enter full-time academic research
careers and compete effectively for individual and collaborative grant support. Due to our reputation for
clinician—scientist training and the diversity of major research areas in vision science that are available to
scholars, we have every year attracted multiple highly attractive candidates for the Wilmer K12 program. Our
structured program still leaves considerable flexibility to take advantage of multiple—mentor groups for training
in a combination of didactic and practical activities. The existence of a Departmental executive committee for
ongoing oversight of every K awardee (K12, K08 and K23) assures that each scholar will be given updated
review of their program and correction of areas that are not functioning ideally. Specific timelines and
guidelines for following of each K scholar program are strictly enforced. Our progress report shows that the
progression to independent research careers and R level funding for Wilmer K12 graduates is far above the
national standard as published. As shown by the faculty involvement of 37 scientists, many of whom were K
awardees themselves, the institutional expertise and commitment to this program is a high priority of the
Wilmer Institute. The combined research grants of the K12 participating faculty comprises a total direct cost
this year of over $30 million. This ensures that adequate funding is available to support the costs of mentored
training that are not covered by the K awards themselves. Wilmer has produced more full time academics and
Department Chairpersons than any other eye institute or department in the U.S. Furthermore, each
K12/K08/K23 scholar at Wilmer benefits from a mentor team than includes not only Ophthalmology faculty, but
scientists from other departments at the Johns Hopkins School of Medicine, Johns Hopkins University, the
Applied Physics Laboratory, and the Bloomberg School of Public Health. These collaborations cross-fertilize
both scholar training and the research environment of the Institute, and have included members of
Departments such as Neuroscience, Medicine, Biomedical Engineering, Epidemiology, International Health,
and Computer Science. The Executive Committee is vigilant to assure that the mentors and mentees are both
fulfilling their roles, with written evaluations at regular intervals. The Executive Committee consists of
experienced and diverse vision scientists, some of whom recently were in K training and others who have over
many years mentored multiple K scholars. The co-Program Director, Dr. Quigley, has mentored over 50
clinician—scientists, including Department Chairs and Division Directors in more than a dozen institutions
nationally and internationally. The other co-Program Director, Dr. Handa, is a distinguished clinician—scientist
with continuous laboratory funding, recently the Chair of a visual sciences NIH study section, past K11
awardee, and with multiple past K mentees.The facilities of Wilmer's clinical and lab research are
unsurpassed, including the 200,000 square foot Smith Building.

Public health relevance
Project Narrative The Wilmer K12 mentored training program has produced 44 vision researchers who carry out investigations into blinding diseases, providing protected time to learn research methods and transition to research-intensive careers to produce of new diagnostic and treatment solutions in ophthalmology.